BRAIN IMAGING STUDIES OF AUDITORY PROCESSING DYSFUNCTIONS IN SCHIZOPHRENIA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Abnormalities in the auditory system have long been suspected to be present among people who suffer from schizophrenia and other psychotic disorders, due in part to the high prevalence of auditory hallucinations amongst these patients. Over the last decade, a group of Australian researchers have identified an index of auditory information processing, recorded from scalp electrodes, that is abnormal in patients with schizophrenia, and their biological relatives. The present project will examine the relationship between these electrophysiological findings, and a new non-invasive technique of functional brain imaging, looking at changes in blood flow, that can identify the specific brain regions that are active during auditory information processing, and link these to the sources of the scalp recorded measures. Both of these functional measures will be examined in relation to the volumes of brain tissue, measured from magnetic resonance imaging scans using new analysis tools, that enable the identification of subtle changes in brain anatomy. By examining patients who have recently developed schizophrenia, those who have suffered from the illness for longer periods of time, and their close relatives, this study will provide the opportunity to identify biological markers of increased vulnerability for the development of schizophrenia.